Global Network for Women's and Children's Health Research Data Coordinating Center

Supplement for the Global Network for Women’s and Children’s Health Research’s A-PLUS Antimicrobial Resistance Study Project Summary The Global Network is currently undertaking a trial of azithromycin to reduce risk of sepsis and newborns (A-PLUS). An important question to understand is the prevalence of antimicrobial resistance among women exposed to azithromycin. Thus, this supplement will be used to support the ongoing serial collection of clinical specimens from mothers and infants, and testing of these specimens for Azithromycin-resistant bacteria by culture to 3 months for all dyads (regardless of resistance at 6 weeks) and a final sample collection between 6 and 12 months post-partum for culture of maternal and infant samples (Nasopharyngeal [NP]and rectal) to also test for Azithromycin-resistant bacteria by culture. Samples from all timepoints will be used to assess the maternal and infant microbiome and to assess the effects of the single dose of prophylactic azithromycin on the resistome by identifying and determining the duration of any potential dysbiosis and presence of resistance genes in the microbial communities. Specifically, supplemental funds to the data coordinating center will support the activities of the sub- study outlined below: • Facilitating sample collection, testing for anti-microbial resistance for 3 month duration followed by final sample collection at 6 and 12 months post-partum in sub-set of mother ?infant dyads • Procuring and shipping supplies for NP swabs and rectal swabs to the 8 Global Network Sites. • Providing labels, tracking and analyses of participant’s enrolled in the sub-study. • Managing the shipments of samples from the 8 sites to UAB for analyses, including: o shipping NP swabs and rectal swab specimens in stabilizing buffer on dry ice from the 8 Global Network Sites to the University of Alabama at Birmingham. o shipping bacterial isolates from routine clinical cultures on dry ice from the 8 Global Network Sites to University of Alabama at Birmingham. • Statistical data analyses of the associations with outcomes to the microbiome and resistome analyses. • maintaining the database with the participant characteristics and outcomes and make these data available for public use, as indicated. In summary, the proposed work will address the global concerns about use of azithromycin in laboring women with a comprehensive evaluation of the risk of azithromycin resistance and the changes in maternal-neonatal microbiome and resistome over time and across the diverse populations enrolled in the Global Network Trial. Without the supplemental funds and the above new studies, we will not be able to optimally determine the extent and duration of risk of antimicrobial resistance patterns in this large multi-country study of women and children who were exposed to azithromycin which may be beneficial in preventing infection/mortality and also be neuroprotective for the children. Furthermore, we will otherwise not be able to complete any of the microbiome studies on stored specimens and will not be able to conduct resistome studies which will provide molecular insights into AMR patterns and thereby provide a more complete picture of the effects of our promising intervention on the AMR and microbiome. Because of the large sample size, multi-country sites, and high quality to detail, this proposal has a unique opportunity to thoroughly answer the question of safety in this simple, low-cost intervention.

Public health relevance
Supplement for the Global Network for Women’s and Children’s Health Research’s A-PLUS Antimicrobial Resistance Study Project Narrative The Global Network is currently undertaking a trial of azithromycin to reduce risk of sepsis and newborns (A-PLUS). Azithromycin, a pregnancy class B macrolide, is a broad-spectrum antibiotic with effects on genital mycoplasma and ureaplasma as well as anaerobes – microbes not covered by narrow- spectrum antibiotics (Subramaniam et al 2018). Azithromycin has a long elimination half-life (68 hours) and high tissue uptake (50 times concentrated in tissue compared to plasma). Thus, it is biologically plausible that even a single 2-gram dose of azithromycin in labor would have effects on the developing infant and the nursing mother. A perinatal pharmacokinetic (PK) study by our group confirmed that a single dose of intravenous azithromycin (500mg/250cc solution given over 1 hour) achieves effective plasma and tissue concentrations, is transported rapidly across the placenta, is detectable in cord blood and amniotic fluid, and is secreted in breast milk at concentrations sustained for 48 hours (Sutton et al 2015). Given these PK parameters, there is biologic plausibility of short and long-term neonatal effects of exposure to azithromycin, especially when considering breastfeeding, that could raise adequate concerns about its safety. Azithromycin resistance is a significant concern globally, as it is increasingly being recommended for first line of treatment for a range of bacterial infections. Azithromycin-resistant S typhi has been reported in South Asia (Hooda et al, 2019) and increasing azithromycin resistance is being reported globally in N. gonorrhoeae (Derbie et al, 2020). A follow-up study of a random subset of children aged 1-59 months in Niger in the MORDOR-I trial, 6 months after the 4th 6-month treatment of azithromycin vs. placebo found macrolide-resistant pneumococcus in the nasopharynx in 12.3% in the azithromycin treated group vs. 2.9% in the placebo group from isolates (Doan et al, 2019). There was also a higher prevalence of known macrolide-resistance markers at both DNA (68% vs 46.7%) and RNA (16.7% vs 2.7%) in rectal swabs obtained from the children (Doan et al, 2019). There are a range of known molecular mechanisms of azithromycin resistance (Gomes et al, 2017) including acquisition of target modifying enzymes produced by rRNA methylases encoded in erm genes or macrolides-inactivation, mediated by esterases encoded by ere(A) or ere(B) genes or by phosphorylases, such as those encoded in the mph(A) and mph(B) genes. Transferable genes (msr(A), mef(A) or mef(B)) appear to encode macrolide-efflux pumps and contribute to azithromycin resistance. The consequences of azithromycin resistance occurring after intrapartum treatment with azithromycin on both mother and baby are not well established. Roca et al reported increased azithromycin resistance in S aureus obtained from serial nasopharyngeal specimens through day 28 postpartum in mothers and babies enrolled in a trial of laboring women in the Gambia (Roca et al, 2016), but no significant increase in azithromycin resistance in S pneumoniae. Followed out to 1 year, azithromycin resistance was still present in S aureus but similar in intervention and control groups (but at a lower prevalence 3.1% vs 2.6% respectively) (Bojang et al, 2018). Similarly S pneumoniae resistance was even lower in both groups at 12 months. Not only are there significant concerns about azithromycin resistance after intrapartum administration, azithromycin with its greater antimicrobial activity (with some microbes potentially being beneficial) may have unintended consequences on the maternal and neonatal microbiomes (dysbiosis) beyond standard antibiotics. Especially concerning is that azithromycin, with its rapid placental transfer, long half-life (3 days) and substantial concentration in breastmilk, is among the antibiotics with broad antimicrobial activity that induces the greatest change in the newborn gut microbiome (compared to standard methods of prophylaxis) – even after a single intravenous dose (Sutton et al, 2015; Subramaniam et al, 2018; Ferrer et al, 2017; Mei et al,2017). In addition, azithromycin exposure may favor initial colonization of the infant gut and nasopharynx by azithromycin-resistant organisms that may persist over time. Antibiotic-resistant organisms tend to be more pathogenic and if they persist could result in persistent dysbiosis, placing the infant at risk of opportunistic infection from azithromycin-resistant organisms, as well as providing a reservoir for transmission of resistance genes. There are few studies specifically evaluating azithromycin exposure and its microbiome effect on mothers and their neonates. In addition, there are no studies evaluating these microbiome changes after intrapartum exposure to prophylactic azithromycin. Given that microbiome dysbiosis has been associated with a number of immune-mediated medical conditions – including obesity, asthma, gastrointestinal disease, and even neurocognitive development, it is imperative to evaluate the longitudinal changes in the maternal and neonatal microbiome (gut and nasopharyngeal) after exposure to prophylactic azithromycin in labor as a measure of the safety of an intervention that may have substantial maternal and neonatal benefits (refs: Slattery, Arrieta, Kuo, Rautava, Sudo, Walker, Bailey, Scott, Wang, Jess, Carlson). Supplemental funds will be used to extend the ongoing serial collection and testing of antimicrobial resistance by culture to 3 months for all dyads (regardless of resistance at 6 weeks) and a final sample collection between 6 and 12 after randomization for culture of maternal and infant samples (Nasopharyngeal and rectal) to test for antimicrobial resistance by culture, microbiome and the effects on the resistome of the single dose of prophylactic azithromycin and determine the duration of potential dysbiosis and resistance genes in the microbial communities. We will test two hypotheses: First, children (and mothers) who receive azithromycin prophylaxis, as opposed to placebo, will have short-term microbial alterations (i.e., dysbiosis or increase in pro- inflammatory microbes) after azithromycin exposure (within the 1 week); however, by the 6-week follow-up visit, there will be no differences between intervention groups. The extended surveillance will allow the potential duration of microbiome dysbiosis to be determined. Second, children and mothers who receive azithromycin vs. placebo will have differences in nasopharyngeal and rectal macrolide- resistance determinants, as well as the overall gut resistome, and duration of persistence of resistance determinants. A particular benefit of testing these hypotheses in the Global Network study is to address these questions in populations with varying microbiomes and resistomes in the azithromycin vs. placebo groups based on the high-quality standardized protocol that is being conducted and regularly monitored in 8 sites globally. In addition, new outputs will be obtained including: a) extending the routine collection of serial specimens for culture and detection of resistance to azithromycin 6-12 months after randomization for all dyads, b) effects of the microbiome on azithromycin and antibiotic resistance genes to 3-month samples on all mothers and babies and c) adding a 6–12-month sample collection for future microbiome and resistome studies. As described below, the resistome studies build on and are specifically informed by the isolates from the mother-baby dyads in which clinical resistance to azithromycin is detected. This allows the AMR of azithromycin to be evaluated in different and complementary ways to fully address concerns of the infectious disease community about the risks of azithromycin resistance globally. Details of each are provided below: Clinical monitoring with culture sensitivity testing: Randomized and treated mothers or their babies diagnosed with infections up to 6 weeks after delivery will have clinical culture and sensitivity testing sent, including azithromycin resistance for clinical isolates. This monitoring is a component of the A- PLUS trial and requires no additional consent. The isolation and identification of dominant bacterial pathogens found in the various infection sites will be performed using site-specific routine clinical and microbial practices. The dominant bacterial isolates will also be challenged for antibiotic sensitivity or resistance to azithromycin (AZM), using standardized procedures and materials. The procedures will be based on the site-specific routine clinical and microbiological practices. The identified pathogens will be summarized overall by treatment arm as well as separately by region, mother vs. infant and infection site. The susceptibility vs resistance to azithromycin will be summarized similarly. A) Extending serial susceptibility monitoring of clinical antimicrobial resistance (AMR) patterns: A subset of maternal-infant dyads at each GN country, regardless of clinical infections, will be randomly selected and serially monitored using Naso-pharyngeal swabs (N-P) and rectal swabs (at baseline 0–1-day, 1 week, 6 weeks, 3 months, and between 6 and 12 months) for development of antimicrobial resistance flora and resistance genes. Testing for azithromycin and other antibiotic sensitivity/resistance will be implemented following collection, including for microbes S. pneumoniae and S. aureus (especially N-P swabs with S. aureus acquired from the anterior nares during N-P collection), and E. coli (especially from rectal swabs, S. aureus may also be captured in rectal samples). The maximal sample size will be 1000 maternal-infant dyads x 2 samples (rectal and nasopharyngeal) x 5 time points = 20,000 serial samples across all 7 GN countries and 8 sites across the world. This is an unprecedented number of high-quality samples collected across the globe and has the potential to address questions beyond any other azithromycin study in relation to risks and benefits of an important but broad-spectrum antibiotic that could cause important AMR harm it not managed appropriately. Attention will be focused on any sample where clinical resistance is detected in either maternal or infant samples. B) Serial sample collection and microbiome analysis: We will assess the gut and nasopharyngeal microbiome of both mothers and neonates over time using 16S rDNA sequencing to monitor for changes in the bacterial microbiome. A subset of samples (derived and parallel with the resistome analysis, see below), would also be analyzed using shotgun metagenomic sequencing techniques to decipher microbiome-host responses. In total, there are 20,000 samples derived from this sub-study (dyad, 2 sampling sites, 5 time points [baseline, 1 week, 6 weeks, 3 months, and between 6 and 12 months ). For this aim, the sample size will be 1000 maternal-infant dyads (using three time points [baseline, 1 week, last available time point] and 2 sampling sites ~12,000 samples) across all GN countries. The remainder of available samples from the maternal-infant dyad will be stored for future hypothesis-driven analysis of extended timepoints. Specific protocols will be used to collect and store specimens properly in -80 degree freezers at each site. Quarterly sample shipments will be sent to the US for microbiome analysis, with the exception of those from India. We will work with the Indian sites to address Government of India requirements that samples collected in India be analyzed in India and, based on preliminary discussions with several microbiome labs, we believe that we will be able to subcontract with a lab in India for both 16s and shotgun metagenomics. The Indian Government will allow QC samples to leave India to evaluate the quality of the 16S analysis and shotgun metagenomics in India. We expect the costs to be similar regardless of where the samples are analyzed, and have addressed this in the budget. The 16S rDNA microbiome analysis will be conducted at the University of Alabama at Birmingham (UAB) Microbiome Resource Center. DNA will be extracted from all samples in standardized fashion, and 16S sequencing and analysis will be conducted at the UAB Microbiome Resource using our standard validated methods (Lal et al, 2016; Subramaniam et al, 2018) to look for changes in the gut and nasopharyngeal microbiome in mothers and their infants over time. Whole shotgun metagenomic sequencing will be performed in parallel with the resistome analysis (done at the University of Massachusetts) on a subset of samples as described in detail below (n=200 at 3 sampling time points x 2 sampling sites). C) Resistome Analysis: Unlike 16S sequencing, which only targets bacterial 16S rRNA genes, shotgun metagenomic techniques sequences allow analyzing the presence and dynamics of “resistomes” (the ensemble of genes encoding antimicrobial resistance in a given microbiome) in disparate microbial ecosystems. It is critical to test the genomic resistance patterns in those samples that test positive for clinical resistance to azithromycin (S. pneumoniae, S. aureus and E. coli). [Cases] – we estimate that there will be at least 100 (10% of the dyads that have resistance in one or more of these organisms) vs. 10% of controls – a random subset of the remaining controls so that we can conduct metagenomic analysis focused on the patterns of resistance genes in serial samples. Both assembly-based and short- read metagenomic analysis approaches will be applied. Antimicrobial resistance (AMR) genes will be identified using the Resistance Gene Identifier (RGI) and the Comprehensive Antibiotic Resistance Database (CARD). Upon determination of AMR content relevant for the metagenomic dataset(s) analyzed, we will quantify the per sample abundance of AMR genes by mapping metagenomic reads to a shortBred data base created from identified ARM gene sequences extracted from the CARD database. shortBred enables inference of AMR gene abundances per sample, normalizing for average read length, marker length, and sequencing depth. Our sample size for this analysis will be as follows: 2,400 samples based on 100 dyads (cases) with resistance in at least one serial sample for azithromycin resistance based on clinical testing of S. pneumoniae, S. aureus or E. coli testing in the nasopharyngeal or rectal specimens over 3 time points closest to when azithromycin is administered (baseline obtained within 24 hours of randomization, 1 week and 6 weeks after randomization). These samples are informed by the clinical testing in the AMR protocol above. Resistance analysis will also be supplemented by metagenomic resistome analysis of specific isolates of S. pneumoniae, S. aureus and E. coli with resistance to azithromycin wherever possible. In summary, the proposed work will address the global concerns about use of azithromycin in laboring women with a comprehensive evaluation of the risk of azithromycin resistance and the changes in maternal-neonatal microbiome over time and across the diverse populations enrolled in the Global Network Trial. Because of the large sample size, multi-country/sites, and high quality to detail, this study has a unique opportunity to thoroughly answer the question of safety in this simple, low-cost intervention.